Oral BCG: Optimizing mucosal vaccination against tuberculosis

Tuberculosis is the second most common cause of infectious death worldwide and preventative
efforts to develop a highly effective vaccine have been unsuccessful thus far. BCG (Bacille-
Calmette-Guerin) vaccination remains the most widely available vaccine against TB, reducing
severe disease in neonates, though its efficacy is only 50% for all forms of TB. We have shown
that changing the route of BCG administration profoundly influences its protective efficacy. In the
macaque model of TB, intravenous BCG provided 90% protection against Mtb challenge. Oral
BCG was the first human vaccine given in infants against TB with good historical safety and
efficacy. Here, we propose to optimize an oral BCG regimen (Aim 1), compare the efficacy of
oral BCG to intravenous and intra-dermal BCG (current human standard) against Mtb challenge
using modern imaging, immunologic (innate and adaptive lymphocyte function, systems
serology, scRNA-seq) and molecular tools (Aim 2). Lastly, we will use computational systems
modeling to identify correlates of vaccine-induced protection against Mtb infection (Aim 3). Data
in this proposal will provide critical information about the efficacy of oral BCG and discover
important measures that correlate with vaccine induced protection and failure. If successful,
such measures could transform the TB field.

Public health relevance
NARRATIVE Tuberculosis (TB) remains a global health threat. We have shown that we can improve the efficacy of BCG Bacille Calmette-Guerin (BCG), the most widely used TB vaccine in the world. This proposal will determine how effective oral BCG vaccination works against standard BCG vaccination methods and identify correlates of vaccine induced protection.